Deep mutational scanning of MYH7 in genome-edited cardiomyocytes

Project Summary
Hypertrophic cardiomyopathy (HCM) is a heritable hypertrophy of the left ventricle that can present as sudden
cardiac death and heart failure. Autosomal dominant missense variants in myosin heavy chain 7 (MYH7) can
cause up to 40% of the familial HCM cases. While accurate interpretation of MYH7 variants can help identify
patients at risk for developing HCM, there are currently ~1,800 MYH7 missense variants in ClinVar that are
variants of unknown significance (VUS), creating diagnostic challenges for clinicians and emotional distress for
patients. Furthermore, because clinical guidelines now recommend that all HCM patients undergo genetic
testing, the number of MYH7 VUS is growing rapidly. Deep mutational scanning (DMS) can help address the
VUS problem by determining the functional consequence of thousands of genetic variants in a single
experiment. By generating accurate variant effect maps that define the function of nearly all possible missense
variants in a sequence of interest, DMS can assist with clinical variant interpretation at scale. So far, deep
mutational scans have been primarily practiced in cancer-derived cell lines, which are not helpful for assessing
genes such as MYH7 that are only expressed in specialized cells like cardiomyocytes. Human induced
pluripotent stem cells (hiPSCs) can differentiate to many cell types, offering a solution to this problem;
however, gene-editing in hiPSCs is generally low throughput. We recently developed a novel gene-editing
technique called CRISPR activation On-Target Editing Retrieval (CRaTER) that can edit hiPSCs at scale,
enabling the generation of large variant libraries in hiPSCs for the first time. To address the growing MYH7
VUS problem, we plan to perform a deep mutational scan of MYH7 in physiologically-relevant hiPSC-derived
cardiomyocytes (hiPSC-CMs). In Aim 1, we propose to generate a single nucleotide variant (SNV) library of
nearly all possible MYH7 SNVs in hiPSC-CMs. We will leverage CRaTER-assisted genome-editing to be able
to generate a hiPSC SNV library at this scale. In Aim 2 we will optimize and validate phenotypic assays to be
able to discriminate hiPSC-CMs expressing pathogenic variants from hiPSC-CMs expressing benign variants.
These phenotypic assays will inform a deep mutational scan of MYH7 that will determine the functional effect
of nearly all possible MYH7 SNVs and assist with clinical variant interpretation. In summary, we will combine
CRaTER, a novel gene-editing technique we developed, with hiPSCs to perform a DMS of MYH7 in genome-
edited hiPSC-CMs. The results will improve the interpretation of ~1,800 MYH7 VUS, enable the interpretation
of thousands of possible MYH7 SNVs that may be encountered in the future, and provide a framework by
which deep mutational scans can be performed in hiPSC-derivatives for the first time, which we believe will be
transformative for the field of variant interpretation.

Public health relevance
PROJECT NARRATIVE Genetic variants in myosin heavy chain 7 (MYH7) are common causes of hypertrophic cardiomyopathy (HCM), a potentially life-threatening heart disease. Most of the MYH7 variants are classified as variants of unknown significance, which affects the ability to accurately identify patients at risk for HCM. This proposal will determine the disease-causing potential of thousands of MYH7 variants to better interpret genetic test results for patients and will identify shared mechanisms by which MYH7 variants cause HCM, which may inform potential future interventions.